SLEEP DEPRIVATION AND BRAIN FUNCTION IN OLDER ADULTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. 1. Compare cerebral responses (fMRI) to cognitive challenege afer normal sleep and after TSD in adults 60y/o. 2. Examine the relationship between cerebral response and performance after TSD. 3. Compare responses of the older adult with young adults.